Endogenous opioid modulation of cortical pain circuits.

Project Summary/Abstract
Chronic pain is a pervasive burden affecting over 50 million US citizens. The experience of pain is subject to
modulation based on context; however, the mechanism of this modulation is unknown. This project aims to
unravel the intricate dynamics of prefrontal cortical microcircuits during expectation-driven endogenous pain
relief, or placebo analgesia. Specifically, this research focuses on mu opioid receptor (MOR) expressing anterior
cingulate cortex (ACC) neurons. This proposal integrates a preclinical placebo analgesia model in mice with
cutting-edge techniques such as in vivo single-neuron resolution calcium imaging and the application of a novel
opioid biosensor (δLight), to investigate the nuanced interplay between nociceptive signaling and the opioid
system within the ACC during placebo analgesia. In Aim 1, viral expression of GCaMP8m under a MOR promoter
(mMORp-GCaMP8m) enables visualization of nociceptive MOR+ neurons during placebo conditioning. In Aim
2, the role of enkephalin in the ACC during placebo analgesia will be investigated through CRISPR-mediated
excision and biosensor-based monitoring. These aims strive not only to elucidate the neural correlates and
potential mechanisms of placebo analgesia, but also to contribute to a broader understanding of how pain is
endogenously regulated in a context-dependent manner by opioid systems in prefrontal cortex.
As a pivotal component of this research endeavor, a training plan is outlined to foster the development of Ms.
Oswell’s skills, preparing her for an independent research career. The successful execution of these aims not
only contributes to the scientific understanding of placebo analgesia but also provides significant training
opportunities, ensuring she is well-equipped with the requisite skills for a future independent research career.
Through hands-on experience in state-of-the-art methodologies, she will acquire expertise that extends beyond
the immediate scope of this project, cultivating a foundation for continued contributions to the broader field of
pain neuroscience. The interdisciplinary nature of this research, combining molecular biology, neuroimaging,
and behavioral analysis, provides a unique platform for skill diversification and the cultivation of a holistic
research perspective. This project holds promise not only for advancing our understanding of pain modulation
but also for shaping Ms. Oswell into a proficient and independent researcher poised to make substantial
contributions to the scientific community.

Public health relevance
Project Narrative This project investigates the neural correlates of placebo analgesia, a phenomenon wherein perceived pain is alleviated by expectation, offering a unique opportunity to dissect the intricate interplay between emotional states and nociceptive processing. Focusing on the anterior cingulate cortex, this project’s aims will investigate the dynamics of nociceptive mu-opioid expressing neurons and the role of enkephalin in placebo analgesia. Through innovative techniques such as in vivo miniscope calcium imaging and a novel opioid biosensor, this research not only contributes to understanding placebo analgesia but also the broader question of endogenous opioid modulation of pain.